Neural network dysfunction in early HIV neuropathogenesis

HIV infection of the nervous system results in chronic infection, inflammation and cognitive decline in many
patients with no effective treatments. Inflammation appears early in the disease process and causes
progressive neural damage due, in part, to factors released by activated microglia and macrophages. In
cultured neurons these factors induce intracellular calcium accumulation, cytoskeletal damage and focal
swelling, much like the early Alzheimer disease (AD)pathology, suggesting a common substrate for disease
progression. In gp120 transgenic mice and AD mouse models we recently identified a unique form of Tau
that accumulated in the neuritic swellings. The same Tau accumulated naturally in the hippocampus of
aging and gp120 Tg mice in parallel with p75NTR expression and Iba-1 immunoreactive microglia suggesting
an important link between inflammation, aging and neurodegeneration. In preliminary multielectrode array
(MEA) studies, these early indices of neural damage and Tau accumulation correlated with the appearance
of burst-like activity patterns, increased spike frequencies and a decreased density of neuron
interconnections, all signs of network dysfunction. At the cellular level, hyperresponsiveness contrasted
with the restricted network activity highlighting the need to better understand how changes in neuronal
function translate to network function. Treatment strategies targeted to these early, reversible
manifestations of the disease process have the potential to stabilize cognitive function and perhaps
suppress pathogenesis. We propose a series of experiments that will provide complementary in vitro and in
vivo analyses of the temporal development of network dysfunction in mouse models of HIV-associated
inflammation. In vitro studies of mixed neural cultures from gp120 Tg, Tau overexpressing, p75
neurotrophin receptor deficient and wild type mice will utilize high content recording of neural activity on
4096 electrode culture grids, calcium imaging of primary neurons, morphometry and immunocytochemistry
to examine the contribution of HIV pathology to the development of neural and network dysfunction under
both normal and disease prone conditions. Parallel studies will examine the relative contribution of
microglia as well as HIV Tat protein. Subsequent microwire array recording in vivo to examine hippocampal
mesoscale neural network activity, communication and function in gp120 Tg mice crossed to Tau
overexpressing and p75 deficient mice will begin to reveal how network behavior is modified as pathology
progresses. Mice with confirmed network dysfunction will be evaluated for cognitive function which will be
correlated with MRI/PET studies of synaptic loss and microglial activation with the SV2A synaptic vesicle
protein probe 11C-UCB-J and the mitochondrial TSPO probe 18F-PBR111, respectively. We believe this
integrated approach will identify and characterize HIV-associated network dysfunction and open new
avenues for disease modifying therapeutic intervention.

Public health relevance
HIV-associated inflammation in the nervous system causes neuronal calcium dysregulation and cytoskeletal damage, including the formation of novel posttranslational modifications of Tau, that contribute to network dysfunction, cognitive deficits and disease progression. These processes appear early in disease but the connection between neural damage and the function of the neural networks that support normal cognition is not well understood. To pave the way for novel disease modifying interventions, the proposed experiments will use in vitro and in vivo high content electrophysiological studies in combination with parallel functional assessments in mouse models of HIV and Tau pathology to: 1) determine how HIV contributes to the generation of aberrant network activity, 2) characterize the properties of the dysfunctional networks and 3) identify strategies to minimize inflammation-associated damage and stabilize network function.